Evaluation of a Place of Last Drink Initiative to Reduce Overservice and Alcohol-Related Crime

Licensed alcohol establishments that serve alcohol on their premises (i.e., bars and restaurants) directly
influence the blood alcohol content (BAC) levels of their customers through their serving practices. Excessive
alcohol consumption at licensed establishments leads to high BAC levels, which in turn leads to increased
impairment and alcohol-related problems such as traffic crashes and violence. Professional service staff who
provide alcohol to individuals who show obvious signs of intoxication (i.e., overservice) contribute to these
problems. Overservice of alcohol is prohibited by law in 48 states but little research has been conducted on
enforcement of overservice laws. Law enforcement agencies are motivated to enforce alcohol service laws but
have limited resources and want guidance on which strategies are effective. We propose to conduct an
evaluation of an innovative overservice enforcement strategy currently being used in communities in Minnesota
as well as other U.S. states—place of last drink initiatives (POLD). In a POLD initiative, when responding to an
alcohol-related incident (e.g., driving under the influence, assault), law enforcement agents ask about and
record the place where an intoxicated individual last drank alcohol. These data are regularly monitored to
identify patterns of overservice of alcohol. Establishments that are regularly identified as a POLD source are
visited by law enforcement, are required to attend training, and/or receive a penalty (e.g., license suspension).
This may lead to fewer sales to obviously intoxicated customers, and ultimately, reductions in alcohol-related
problems. We propose a three-year study to assess the following aims: (1) evaluate effects of POLD
enforcement on alcohol-related crime in POLD vs. comparison communities, (2) assess likelihood of
overservice of alcohol at alcohol establishments in POLD vs. comparison communities, (3) assess
attitudes/perceptions and policies/practices pertaining to responsible service and overservice enforcement
among manager and servers of alcohol establishments in POLD vs. comparison communities. Findings will
provide guidance for law enforcement agencies attempting to reduce overservice of alcohol and alcohol-related
problems and inform future randomized control trials.

Public health relevance
Irresponsible alcohol service at bars and restaurants increases patron intoxication levels and related problems such as violent and non-violent crime. Regular monitoring and enforcement of serving practices puts pressure on bars and restaurants to serve alcohol responsibly. We will evaluate whether a unique enforcement intervention developed by law enforcement agencies improves serving practices in bars and restaurants and helps reduce crime.